TREATMENT OF DEEP VEIN THROMBOSIS WITH UROKINASE, STREPTOKINASE AND HEPARIN

Thrombi formed in the veins of the lower extremities will disturb the architecture of the venous structures and can result in the post-phlebitic syndrome. The purpose of this study is primarily to evaluate the efficacy of streptokinase and urokinase as compared to standard anticoagulant therapy with heparin in the dissolution of deep-vein thrombosis.